An implantable hemodialyzer for treatment of End-Stage Renal Disease

DESCRIPTION (provided by applicant): End-Stage Renal Disease (ESRD) affects just over 600,000 people in the United States and costs Medicare ~$33 billion annually. In-center thrice-weekly hemodialysis is the most commonly performed treatment for ESRD, but it suffers from poor 5-year survival rates, reduced patient quality of life, and is costly. In contrast, daily-extended hemodialysis has demonstrated 5-year survival rates similar to kidney transplant and has improved intermediate outcomes. Even though daily-extended hemodialysis yields superior outcomes than in- center thrice-weekly hemodialysis, it is performed by less than 1% of the ESRD population because it is too costly to perform in-center and too complex to perform at home. Current home hemodialysis systems require patients and caregivers to perform complicated tasks associated with life threatening risks, such as self-care needle sticks. The superior outcomes but low adoption rate of daily-extended home hemodialysis creates an opportunity for a simple-to-use and safe home hemodialysis system. The long-term objective of our project is to create a new home hemodialysis system (nHHD) that will increase the practice of daily-extended home hemodialysis and improve End-Stage Renal Disease (ESRD) outcomes. This NIH SBIR Phase I proposal aims to demonstrate the feasibility of the nHHD that will empower ESRD patients to perform daily-extended home hemodialysis and consequently receive the associate health benefits.

Public health relevance
PUBLIC HEALTH RELEVANCE: End-Stage Renal Disease (ESRD) affects over 600,000 people in the US and costs Medicare approximately 33 billion dollars annually. Silicon Kidney is developing a new dialysis treatment that will improve ESRD patient outcomes, increase patient quality of life, and significantly reduce Medicare's expenditures on ESRD.